Initial validation of a novel pre-screening tool for HIV-associated CNS impairment: The Virtual Driving and CNS Assessment System (VDCA)

Project Summary and Abstract
The standard paradigm for the detection of HIV-associated CNS impairment (HIVCI) involves protocols that
require trained personnel, often impractical and unavailable in typical outpatient clinical settings. As a result,
HIVCI is often undetected or detected late, leading to a lower quality of life and decreased survival. With the
need for earlier detection and the availability of new medical billing codes, a recent push to change the
paradigm towards earlier screening of cognitive impairment as a precursor to diagnostic testing is currently
underway; however, severely limited in its capability and scope. Therefore, there is an urgent need to enable
this new paradigm to detect HIVCI earlier in the disease course (a topic area of interest to NIMH’s Division
of AIDS Research and HIV Neuropathogenesis Program): universal screening (not requiring trained staff) to
reliably refer HIV+ patients to neuropsychometric (NP) diagnostic testing (by trained staff). This SBIR
proposes a novel value proposition: A universal screening tool based on a known functional
impairment - driving. Thus, the long-term goal of this SBIR is a new Virtual Driving and CNS
Assessment System (VDCA) as a valid, low cost, easy-to-administer, universal screening system for
HIV+ patients. To achieve these objectives and develop the VDCA, we will leverage (1) our
commercially-successful virtual driving test (VDT) as a platform on which to develop the VDCA; (2) our team’s
scientific know-how in utilizing driving to task cognitive, sensorimotor and memory systems (including those
implicated in HIVCI); (3) our exclusive access to an established longitudinal cohort of HIV+ participants; and (4)
novel neuroimaging methods to detect HIVCI pathogenesis. Our preliminary work using
magnetoencephalography (MEG) supports the development of the VDCA as a meaningful probe of cognitive
control and functional capacity that will become a universal screen for HIVCI. In this supplement, we propose
one additional aim building off of the successful work conducted in parent SBIR award, before pursuing a
larger Phase II project: Aim 1: Conduct a feasibility imaging study to quantify HIVCI pathogenesis in the
executive network of the frontal cortex as measured by VDCA performance. These insights will provide
support for the utility and feasibility of the VDCA as a universal screen and set the direction for future
refinement, testing and evaluation in Phase II.

Public health relevance
Project Narrative We will demonstrate that our new Virtual Driving and CNS Assessment System (VDCA) can differentiate HIV+ patients with and without HIV-associated CNS impairment (HIVCI). To accomplish this, we will leverage our exclusive access to an established HIV+ longitudinal cohort, conduct detailed neuropsychometric testing to confirm the presence or absence of HIVCI and link this data to individualized VDCA performance results and neuroimaging results. If this SBIR Phase I finds the VDCA successful in differentiating patients with and without HIVCI, we plan to: (1) conduct a larger study to evaluate the VDCA’s predictive ability in accurately screening for HIVCI; and (2) shift the current paradigm for the assessment and diagnostic testing of HIVCI by delivering the first reliable, valid, and low-cost universal screening tool for HIVCI for use in clinical and resource-limited settings.